Solid-state nanopore detection of protein biomarkers for early sepsisdiagnosis

Summary
Sepsis is life-threatening organ dysfunction due to a dysregulated host response to microbial infection, and is a
global healthcare problem with high incidence and mortality rates, responsible for 20% of deaths worldwide. In
the USA, sepsis is the most common cause of death among hospitalized patients and the total hospital costs of
treating sepsis are estimated at more than $24 billion annually. The high mortality rate of sepsis is due in part to
delays in diagnosis and management, as a result of its initial atypical and nonspecific symptoms and lack of early
and sensitive diagnostic test. The goal of this program is to develop an ultra-sensitive, highly selective, and
portable solid-state nanopore sensing platform to profile a panel of sepsis protein biomarkers in clinical samples
instead of one specific biomarker as currently used in the clinical setting to provide more comprehensive
parameters for accurate diagnosis of sepsis at the early stage and monitoring the treatment prognosis.
Aim 1: Utilize procalcitonin (PCT) as a model protein to demonstrate the feasibility of utilizing our
proposed solid-state nanopore sensing strategy, which takes advantage of a combination of magnetic beads,
sandwich immunoassay, DNA reporter probe cascade and amplification, and DNA-functionalized
gold nanoparticles (AuNPs), as an effective generic approach for the sensitive and accurate detection of proteins
in clinical samples. To optimize the sensor sensitivity, the effects of various factors such as incubation time,
denature temperature, AuNPs diameter, DNA reporter probe length, nanopore dimension, etc. on PCT detection
will be examined by using a silicon nitride nanopore. Furthermore, we will construct dose-response curve for
PCT, and perform selectivity study & simulated serum sample analysis.
Aim 2: Build on the nanopore-based PCT detection methodology developed in aim #1 to develop a
nanopore-based multiplexing sensing platform for simultaneous detection and quantification of multiple sepsis
protein biomarkers. An array of seven silicon nitride nanopore sensors will be constructed and used to
quantitatively detect PCT, C-reactive protein (CRP), interleukin-1 (IL-1), IL-6, presepsin (soluble CD14 subtype),
tumour necrosis factor-α (TNF-α) and lipopolysaccharide (LPS) in protein mixtures at various concentrations.
Aim 3: Analyze clinical serum samples. To evaluate the effectiveness of utilizing our developed solid-
state nanopore sensing platform for accurate sepsis diagnosis and prognosis, the multiplexing nanopore sensor
array developed in aim 2 will be used to analyze 120 clinical serum samples from sepsis patients at different
stages and healthy controls, as well as from sepsis patients who received antimicrobial therapy. The
concentrations of PCT, CRP, IL-1, IL-6, presepsin, TNF-α and LPS in these serum samples will be determined.
In comparison, these samples will additionally be analyzed using ELISA detection kits.

Public health relevance
Project Narrative Sepsis is a global healthcare problem with high incidence and mortality rates, responsible for 20% of deaths worldwide. The goal of this program is to develop an ultra-sensitive, highly selective, and portable solid-state nanopore sensing platform to profile sepsis protein biomarkers in clinical samples and take advantage of a panel of protein markers instead of one specific biomarker as currently done in the clinical setting for rapid and more accurate sepsis early diagnosis and prognosis. Success in this endeavor will be followed by extensive work to construct multi-channel nanopore measurement systems for high-throughput sepsis diagnosis, which should have a broad impact on a variety of areas such as clinical diagnosis, pharmaceutical industry, biosensing, and nanotechnology, offering the potential to lead to remarkable improvement in many facets of human life and society.